Novel Broad Spectrum Inhibitors of Dihydrofolate Reductase (DHFR) for Treatment of Infections from High Threat Fungal Pathogens

Project Summary
There is a worldwide need for improved treatment of systemic, life-threatening fungal infections.
Current therapies are limited by the small number of approved drugs, toxicities, drug-drug
interactions, mode of administration, and growing problems of drug resistance and emerging
pathogens. Treatment also suffers from a lack of rapid clinical diagnoses, leading to dependence
on broad-spectrum antifungal drugs. Moreover, existing antifungal drug classes target membrane
and cell wall integrity, and there is a need to develop drugs against targets with new modes of
action to minimize cross resistance. Available evidence suggests dihydrofolate reductase (DHFR)
might be one such target. Commercial DHFR inhibitors are available for other therapeutic
indications (immunology, oncology, antibacterial, antiparasitic). Bactrim® is the only available
DHFR inhibitor for fungal infections but has a very narrow spectrum of activity (Pneumocystis
jirovecii and Paracoccidioides spp.), despite DHFR being an essential enzyme that is highly
conserved in fungal pathogens. As demonstrated in the current work, Candida spp., Aspergillus
spp., Cryptococcus spp., rare molds, Mucorales and dermatophytes are susceptible to DHFR
inhibition, and the DHFR mechanism of action is complementary to the targets of existing
antifungals. Fungal DHFR inhibitors have been identified that inhibit the enzyme selectively and
fungal cell growth in vitro, and fungal DHFRs differ in structure sufficiently from human DHFR
indicating that development of selective DHFR drugs is feasible. The specific aims of this Fast
Track proposal are to (1) reduce serum antagonism of our initial fungal DHFR inhibitors and
demonstrate in vivo efficacy, (2) optimize a lead fungal DHFR compound or series to select a
potential development candidate and (3) validate a fungal DHFR lead (or leads) and select a
single candidate for IND-enabling studies. The approach will enable a robust lead optimization
program to accomplish the aims and will include analog synthesis and computational chemistry,
biochemical, structural, and modeling studies, whole-cell assays, in vivo models (i.e., efficacy,
pharmacokinetic and pharmacodynamic) and in vitro ADME/Safety profiling to synthesize and test
inhibitors against fungal and human DHFR enzymes, fungal pathogens, and mammalian cells.
The outcomes will advance this program into IND-enabling studies (Phase IIB). The long-term
objective is to develop fungal-selective DHFR inhibitors into a new class of broad-spectrum
antifungal drugs.

Public health relevance
Project Narrative The World Health Organization (WHO) released a report in October 2022 highlighting the increasing worldwide threat of invasive fungal infections, including drug-resistant infections, especially among expanding populations of immunocompromised individuals (https://www.who.int/publications/i/item/9789240060241). Its goals were to direct attention to the growing problem of fungal diseases, to galvanize support for public health measures, to promote research and development (R&D) in this area, and to support development of new therapies to treat fungal infections. This proposal is a collaborative effort between industry experts with decades of experience in antimicrobial drug R&D and university scientists that aims to develop novel inhibitors of fungal DHFR, an essential fungal target with a unique mode of action, into new, broad-spectrum drugs to tackle the problem of emerging and drug-resistant fungal infections.